Survivorship and Access to care for Latinos to Understand and address Disparities (SALUD)

ABSTRACT
Pediatric cancer survivors (PCS) experience an excess risk of adverse outcomes related to their cancer
diagnosis and the treatment they receive. The accumulation and severity of these acute and chronic health
conditions broadly impact PCS functioning, quality of life, and health care resource utilization. Consequently,
PCS are more likely to live in financial hardship, have lower educational attainment, be unemployed due to poor
health, and be under- or uninsured compared with their age-based peers. Latino PCS are at particularly high risk
for having a lower socioeconomic status (SES compared with non-Latino PCS. These factors contribute to
reduced access to routine medical care, and lower overall survival of Latino children diagnosed with cancer.
Existing and well-established patient cohorts of PCS largely include long-term (at least 5 years) survivors and a
relatively small proportion of Latino PCS, so that the outcome data that inform our understanding of risk for
cancer treatment late effects, and therefore our clinical practice guidelines, are largely derived from the
experiences of NHW PCS. The over-arching objective of this proposal is to identify and comprehensively assess
adverse outcomes among Latino PCS that will inform clinical guidelines and lay the foundation for early, targeted
interventions to mitigate such outcomes in this vulnerable and growing population of PCS. Key to the success of
our proposal is the prospective establishment of a Latino PCS cohort in Texas that is linked with genomic and
geographic data (UG3 planning phase), which will permit analyses of the interaction between ancestry and SES
on risk for adverse cancer treatment outcomes during the UH3 implementation phase. There is a significant
unmet need to comprehensively characterize the socioeconomic, psychosocial, genomic, and metabolomic risk
determinants of treatment-related toxicities and relapse in Latino PCS in the context of known clinical risk factors.
In addition, among under-represented minorities there is a critical need to identify facilitators and barriers to
obtaining survivorship care. Therefore, utilizing existing and prospectively collected longitudinal data, we will: (1)
Identify demographic, clinical, and genetic/molecular determinants of treatment-related toxicities and their
association with chronic health conditions, patient-reported symptoms, and neurocognitive/ psychological and
functional outcomes in Latino PCS; (2) Identify demographic, clinical, and genetic/molecular determinants of the
excess risk of cancer relapse/recurrence in a cohort of Latino PCS; and (3) Determine Latino PCS understanding
of risk for late effects and rationale for survivorship care, and identify perceived facilitators and barriers to
obtaining survivorship care. This proposal synergizes multidisciplinary expertise and data collected from clinical
and epidemiological resources to establish a prospective, comprehensive biobank and database inclusive of a
large population of Latino PCS. Our aims represent the largest assessment to date of genetic and SES
contributors to outcomes in Latino PCS, an effort that is imperative to inform risk assessments for adverse
outcomes in an ethno-diverse population, as well as potential barriers to obtaining optimal survivorship care.

Public health relevance
PROJECT NARRATIVE Pediatric cancer survivors (PCS) experience an excess risk of numerous adverse outcomes related to their cancer diagnosis and treatment, which impact social functioning, quality of life, and health care resource utilization. Latinos, in particular, are more likely to experience these adverse outcomes and have reduced access to routine medical care, contributing to higher morbidity and mortality among Latino children diagnosed with cancer. Existing and well-established cohorts of PCS exclusively include long-term survivors with a relatively small proportion of Latino PCS; therefore, the data that inform our understanding of risk for treatment-related late effects, our clinical practice guidelines to address them, and the uptake of survivorship care in this vulnerable and growing population are deficient.